Developmental Research Program

Developmental Research Program - SUMMARY/ABSTRACT
The purpose of the Developmental Research Program (DRP) is to fund promising projects by investigators
whose current work may not focus exclusively on hepatocellular carcinoma, but who propose highly innovative
translational studies of hepatocellular carcinoma that could become full SPORE projects or compete successfully
for funding outside of the SPORE. The DRP provides a unique venue for making available significant financial
support, and for demonstrating active institutional support, through a program that is rapidly responsive to new
ideas or initiatives. Moreover, this program is rooted in a spirit of collaboration espoused by the SPORE
investigators, who have an extensive track-record of bringing investigators from other disciplines into
hepatocellular carcinoma research. The strength of the Developmental Research Program rests in its ability to
make available financial support needed to access all the critical expertise and resources within the entire
SPORE. This will allow us to develop collaborative, multi-investigator, multi-institutional research projects with the
support of innovative, investigator-initiated projects that have the potential to flourish into reliable and productive
translational research projects that make a path from basic and/or population research projects into research
focused on human clinical specimens/patient populations.

Public health relevance
Developmental Research Program - NARRATIVE The Developmental Research Program (DRP) will support innovative and scientifically-sound projects that investigate questions pertaining to translational research in hepatocellular carcinoma. This program will allow us to recruit new investigators into the hepatocellular carcinoma research community and identify potential new projects for the Hepatocellular Carcinoma SPORE.